STRUCT CHARACTER OF PROTEIN NUCLEIC ACID COMPLEXES INVOLVED IN NUCLEAR IMPORT

Nuclear import of proteins and nucleic acids is central to many cellular processes and cell-pathogen interactions. Some bacteria and viruses encode specialized proteins that transport genomic DNA and RNA molecules of the invading pathogen into the host cell nucleus. One of these is the VirE2 protein of Agrobacterium. Agrobacterium elicits neoplastic growths on many plant species by transporting a single-stranded copy of the bacterial transferred DNA (T-DNA) into the plant cell nucleus. VirE2 alone appears to be sufficient to transport T-DNA into the host cell nucleus. Since the T-DNA is not sequence specific, the complex between any ssDNA and VirE2 is competent for active nuclear import. M13 ssDNA and VirE2 were incubated and examined in the STEM. Both freeze-dried and negatively stained specimens were prepared. The rather rigid uniform filaments were analyzed, including mass/length, radial density profile analyses, and modeling to fit the observed stained data. A model of a hollow phone-cord like coil, 12.6 nm in diameter, with a helical pitch of 4.4 rim, and approximately one VirE2 per twenty bases, fits all the data.